Deciphering structure-function relationship in large protein complexes by modeling

Project Summary
Most biological systems consist of many components (proteins, RNAs) that work together in a cooperative
manner to carry out specific functions, for example the ribosome for protein synthesis and the bacterial flagellar
motor for locomotion. One of the most important questions in biology is how “structure determines function”. As
the structural information for these complexes becomes available thanks to the recent development of high
resolution techniques such as Cryo-electron microscopy and tomography, the challenge is how this structural
information can be used to understand functions of these large complexes. The overall goal of this project is to
address this challenge by developing structure-based models to bridge the gap between structure and function
for large biological complexes. The structure-based mathematical models, which explicitly include interactions
of different components in the complex based on the complex structure, will be used to study/understand the
emergent dynamic properties of the complex and its input-output relationship in wildtype complex and different
mutants.
In the next funding period, we will focus on studying the structure, function, and dynamics of two large protein
complexes that are ubiquitous in the bacteria kingdom. The first functional complex we will study is the
bacterial MCP chemoreceptor cluster, which serve important cellular functions such as signal amplification and
enhancing adaptation. The fine structure of the MCP cluster is solved by cryo-EM studies, which show that the
core functional unit consists of 2 trimers of dimer (TOD) of the MCP receptors connected by two CheW
molecules and one CheA dimer and these basic units connect with each other through interactions between
CheW and CheA to form a regular two dimension lattice with six-fold symmetry. In this project, we plan to
develop a model of the chemorecptor cluster that include all pair-wise interactions among the key proteins
(MCP receptor, CheW, and CheA) based on the fine structure of the chemoreceptor clsuter, and use it to
investigate the molecular mechanism underlying signal amplification, the functional role of the coupling protein
CheW, and statistics of the stochastic switching dynamics of the MCP cluster in single cells. The second
functional complex we plan to study is the bacterial flagellar motor (BFM) complex, which drives the motility
and chemotaxis motion of bacteria. Recent cryo-EM studies of the BFM stator structure showed that the power
generating stator unit consists of a MotB dimer surrounded by a MotA pentamer ring, which suggested a new
mechanism for how proton-motive-force(PMF) is used to generate rotation of the rotor and how BFM switch
between clockwise (CW) and counter clockwise (CCW) rotations. In this project, we plan to develop a
structure-based model that describes the interactions between MotA and MotB in the stator unit and those
between MotA and FliG subunits of the rotor as well as the proton-assisted conformational changes in the
stator unit based on the stucture of the BFM complex. We will use the struture-based model to
understand/explain all the relevant BFM behaviors which include the PMF-driven rotational dynamics, the CW-
CCW switching dynamics, and the mechano-adaptation in BFM within the same unified modeling framework.
Although we will initially focus on the MCP cluster and the BFM complex, we will look out for other
opportunities in modeling functions and dynamics of other protein complexes.
Throughout our study, results from our models will be compared with exsiting experimental data to guide the
model development, and the predictions from our models will be tested in our collaborators’ labs to further
verifiy and refine/improve them. Combined with quantitative functional measurements, the structure-based
models can be used to explain expeirmental observations under different external and internal conditions
within an unified structure-based framework, and they may also reveal possible new molecular mechanisms
underlying the structure-function relation in large multicomponent complexes. This general approach should be
applicable to study other large biomolecular complexes.

Public health relevance
Project Narrative-Relevance The concepts and tools developed in the quantitative modeling of different biological complex with mutliple subunits will be useful in understanding functions and dynamics of other biological complexes in all living systems, including human. The molecular level understanding of signal transduction and motor functions in large protein complexes is important to study the mechanisms of signaling and transport processes that are critical for human health.